Bioinformatics

BIOINFORMATICS SHARED RESOURCE
Project Summary/Abstract
The UNMCCC Bioinformatics Shared Resource supports basic and advanced bioinformatics needs, including
analysis of high throughput genomic sequencing, high-throughput drug screening cheminformatics, target
analytics and pharmacoinformatics. Faculty Director Yan Guo, Ph.D. (CMO) supervises the Resource with two
additional associate directors, Jeremy Edwards Ph.D. (CMO) and Tudor Opera Ph.D. (CT). The Bioinformatics
Shared Resource is operated by two full-time staff. The Cancer Center Research Administration manages the
Resource, which provides several types of services including quality control, processing and analysis of newly
generated genomics data, secondary analysis of existing genomics data, study design, manuscript and grant
support. Reservations, billing and usage are tracked through an in-house developed SQL database. The
Resource Director and staff worked closely with the Research Programs to develop new methodologies that
promote innovative basic and genomics research goals and the Resource actively facilitates and disseminates
information about new bioinformatics technologies by maintaining an up-to-date web page and by giving
presentations/seminars at UNMCCC meetings and retreats. During the previous 5-yr project period, 35 PIs used
services from the Bioinformatics Shared Resources, a substantial increase from the 24 users from the previous
period. Among them, 30 were UNMCCC members from the three Research Programs. Also during the last
cycle, the Bioinformatics Shared Resources assisted with the publication of 20 scientific manuscripts.
Furthermore, the Bioinformatics Shared Resource supported the submission of 28 national grants (20 NCI and
8 non-NCI). Nine of them were funded and are currently supporting activites in the Bioinformatics Shared
Resource. Nine grants are currently pending review.